Mending a Broken Heart Allocation System with Machine Learning

PROJECT ABSTRACT
Heart transplantation is a life-saving treatment for end-stage heart failure, a devastating disease which kills over
250,000 Americans each year. Unfortunately, the supply of deceased donor hearts cannot meet demand, and
over a third of candidates will die or be delisted without transplant. In the context of such scarcity, allocation must
make the best use of scarce deceased donor hearts by ranking candidates from most to least medically urgent.
In contrast to other organ transplant systems, there is currently no objective score used to rank heart transplant
candidates on the waitlist. Instead, each candidate’s priority for transplantation is based on “Status,” a
designation determined by the supportive therapy prescribed by their transplant center. I have previously shown
that some heart transplant centers appear to overtreat candidates with intensive therapies at far higher rates
than other centers. My preliminary data demonstrates that these practices have consequences for heart
allocation effectiveness. High survival benefit centers reserve intense supportive therapy for candidates who
have poor prognoses without transplant, saving lives by prioritizing the sickest patients. In contrast, low survival
benefit centers list stable candidates and escalate the use of supportive therapies. Based on these data, there
is a clear need for a new system to fairly allocate donor hearts. The overall objective of this K08 application is to
develop and simulate a novel Heart Allocation Score (HAS) designed to objectively identify the candidates who
gain the greatest survival benefit from heart transplantation. Previous attempts to develop such a score using
conventional statistical methods have been inaccurate, but cutting-edge machine learning (ML) techniques
outperform conventional regression models in many clinical contexts. In addition, a new open-source Heart
Simulated Allocation Model (HSAM) is needed to compare policy alternatives because the available program is
closed-source, inflexible, outdated, and structurally unable to simulate allocation scores developed with ML. My
overall hypothesis is that a HAS developed with ML will lead to policy that optimizes heart allocation. I will test
this hypothesis in three Aims. In Aim 1, I will use the complete national transplant registry dataset (N = 109,315
adult candidates) to predict waitlist survival, comparing ML prediction models to the current therapy-based
system. In Aim 2, I will use the same registry to predict post-transplant survival for heart recipients, comparing
conventional statistical methods to ML. In Aim 3, I will develop a) a new, open-source HSAM which I will use to
b) compare current policy to a novel HAS policy constructed from the best prediction models from Aim 1 & 2. My
overall career goal is to save lives by designing delivery systems that fairly and efficiently distribute scarce
medical resources. To accomplish this, I plan to earn a PhD in Health Services Research focused on ML,
simulation modeling, and health policy. Achieving the goals of this proposal will lead to the foundation of a novel
heart allocation system that has the potential to save lives and equip me with the skills needed for future R01-
level applications in the field of scarce healthcare resource allocation.

Public health relevance
PROJECT NARRATIVE: Heart transplantation is a potentially life-saving treatment for end-stage heart failure but unfortunately donors are scarce and only a fortunate minority of patients receive hearts. Current heart allocation policy relies on the intensity of treatment to decide who receives a heart, but this system cannot consistently identify the sickest candidates who stand to benefit the most from heart transplantation. This proposal aims to improve heart allocation by 1) developing a data-driven, objective heart allocation score with cutting-edge machine learning techniques, and 2) building novel, more flexible simulation software.